Leveraging Social Networks to Promote Sexual Assault Recovery and Reduce Drinking to Cope through a Web-Based Intervention

PROJECT SUMMARY
Sexual assault is a persistent public health problem that affects a substantial proportion of college women and
is often associated with increases in heavy drinking to cope with post-assault distress. Survivors often recover
within social networks such as sororities where heavy drinking is normative, and recovery alongside heavy
drinking peers can exacerbate survivors’ drinking to cope. To address this problem, the current application
involves the development of a novel intervention designed to promote effective support of survivors within
social networks of sororities. Support behaviors incompatible with heavy drinking are expected to increase
perceived support among survivors and reduce alcohol use and related consequences among all intervention
recipients. The research plan involves: (1) developing a new web-based intervention in collaboration with
community stakeholders, (2) testing the feasibility of the intervention within a pilot cluster randomized trial, and
(3) examining network characteristics associated with adoption of support behaviors. This Mentored Clinical
Scientist Research Career Development Award (K08) will provide Dr. Anna Jaffe with the research support and
training needed to become an independent researcher in the field of alcohol research. Dr. Jaffe has a strong
foundation researching the intersection between alcohol use and sexual assault, but requires additional
training to become an intervention researcher capable of contributing to broad change by leveraging
technology to administer brief interventions within social networks. To facilitate this training, Drs. Mary Larimer,
Christine Lee, and Cynthia Stappenbeck will provide mentorship in intervention development and evaluation
with relevance to alcohol use, peers, and sexual assault. Additionally, Drs. Nancy Barnett and Tyler
McCormick will provide mentorship in social network methodology and related statistical analyses. The
University of Washington is an ideal environment for conducting this research and obtaining the content,
methodological, and statistical expertise necessary to develop an independent career in alcohol intervention
research. The proposed project will provide pilot data to support a R01 submission to test the intervention on a
larger scale and evaluate the spread of supportive behaviors through social networks. This highly innovative
research plan is consistent with NIAAA strategic goals in the creation of a low-resource technology-based
intervention that has the potential to significantly impact public health by improving peer support to survivors of
sexual assault and reduce heavy drinking on a broad scale.

Public health relevance
PROJECT NARRATIVE After a sexual assault, peers often express confusion about how to best support survivors and may encourage drinking to cope, which can exacerbate the wide range of physical and mental health problems survivors experience, contributing to persistent distress, long-term healthcare costs, and loss of productivity. The current project involves the design and feasibility testing of a novel web-based intervention to increase effective peer support of survivors by focusing on behaviors incompatible with heavy drinking, which will in turn reduce alcohol use and related consequences within high-risk social networks of sororities. If feasibility and preliminary intervention effects are supported, this intervention could be widely disseminated and facilitate change in drinking norms among social networks of young adults, as well as mitigate distress after sexual assaults.